PKC delta as a central mediator of osteogenic signaling

DESCRIPTION (provided by applicant): Diseases of low bone mass, particularly osteoporosis, have gravely impacted society, causing massive disability. Current therapies for the restoration of bone mass are limited and focus primarily on the attenuation of osteoclast activity. The development of anabolic therapies that stimulate osteoblast activity and bone mass acquisition is essential; however, our understanding of the underlying mechanisms regulating osteogenic differentiation and bone formation is still incomplete. The work proposed in this grant aims to expand on our knowledge of the molecular mechanisms involved in bone mass acquisition by assessing the role of protein kinase C delta (PKCδ) in bone. Although PKCδ-/- mice exhibit reduced embryonic bone formation and a cell autonomous defect in osteoblast differentiation from embryonic limb primordial cultures, indicating involvement of PKCδ in embryonic osteogenesis, a role for PKCδ in post-natal osteoblast function and the molecular targets of PKCδ action in skeletal cells have not been established. Our lab has shown that PKCδ regulates the Runx2 activity, one of the master regulators of osteogenesis, thereby presenting a possible mechanism by which PKCδ can impact osteogenic differentiation. The central hypothesis of this grant application is that that PKCδ is a critical factor in multiple signaling cascades that converge on Runx2 and promote osteogenesis and increased bone formation. There are two specific aims to address this hypothesis. (Specific Aim 1) To examine the effect of PKCδ deficiency on osteoanabolic signaling downstream of multiple pro-osteogenic factors in vitro. (Specific Aim 2) To characterize the in vivo impact of loss of PKCδ in the cells of the osteoblastic lineage on post-natal bone formation. Cell and molecular biology, as well as in vivo genetic models, will be used to resolve key knowledge gaps regarding the role of PKCδ in bone. Defining these mechanisms will provide critical understanding into how PKCδ ultimately affects osteoblast function and bone mass acquisition. Hopefully, the knowledge gleaned from these studies will aid in the development of rational therapies against low bone mass disorders that stimulate the formation of bone by targeting pathways that converge on Runx2 via PKCδ modulation.

Public health relevance
PUBLIC HEALTH RELEVANCE: This grant contains research that is concerned with diseases of low bone quality such as osteoporosis. The successful completion of this research could open up new possibilities for therapeutic intervention and treatment of these disorders.